Project IV

Project Summary
Preeclampsia (PE) affects 5-7% of all pregnancies in the U.S. Despite being a leading cause of maternal death
and perinatal morbidity, the most widely accepted treatment is early delivery of the baby. Healthy pregnancy is
associated with elevations in progesterone and CD4+THelper 2 cells/uterine, NK (non-cytolytic) profile favoring
feto-immunotolerance. However, in PE CD4+THelper 1 cells are increased which allow the release of cytokines
and B cells producing autoantibodies (AT1-AA) that contribute to hypertension, endothelial dysfunction and
intrauterine growth restriction (IUGR). An important anti-inflammatory protein secreted from progesterone
stimulated lymphocytes is PIBF-progesterone induced blocking factor which is decreased in pregnancy
disorders. Importantly, PE patients delivering at UMMC have significantly lower circulating progesterone
compared to normotensive pregnant women. Progesterone, in the form of 17-OHPC, was commonly used as
early as 20 weeks of gestation for cessation of recurrent preterm labor in pregnancies not complicated by PE.
However, whether or not 17-OHPC impacts factors that link abnormal maternal vascular and placental function
with inflammatory mediators in PE is unknown. Our preliminary data show that PE patients have less PIBF and
Progesterone and that supplementation with 17-OHPC improves PIBF levels. Associated with this change are
lower inflammatory mediators and blood pressure which increases time to deliver by 50% in PE patients.
Although we show that 17-OHPC improves pregnancy outcomes and PIBF, we don’t know if it is through PIBF.
We hypothesize that decreased Progesterone/PIBF leads to decreased γδ T cells, TH2, uNK, and IL-4, which
allows for increased TH1, cNK and inflammatory cytokines that stimulate vasoactive factors ET-1, AT1-AA, and
sFlt-1 acting in concert to cause endothelial dysfunction (increased UARI), HTN and IUGR during PE. In order
to answer this question, we will utilize a novel model of adoptive transfer of placental CD4+ T cells from PE
women into pregnant nude athymic pregnant rats. This model of PE is characterized by HTN, decreased fetal
weight, increased cytokines, ET-1 and sFlt-1 and AT1-AA. Pregnant nude athymic rats will be treated with CD4+
T cells from PE women with 17-OHPC administered during pregnancy and compared to rats with control PE
CD4+ T cells. We will test the role of PIBF as the mechanism of improve pregnancy outcome through PIBF
blockade in recipient rats of CD4+ T cells from PE women treated with 17 OHPC during pregnancy. Aim 1. To
continue a clinical trial testing the hypothesis that administration of 17-OHPC to PE patients stimulates γδ T cells,
PIBF and reduces inflammation, UARI, AT1-AA, sFlt-1, ET-1, and thus HTN and IUGR during pregnancy. We
will also determine if 17-OHPC increases time to delivery in treated vs. untreated PE participants. Aim 2. To test
the hypothesis that CD4+ T cells from PE women treated with 17-OHPC do not cause a PE phenotype in
pregnant nude athymic recipient rats. Aim 3. To test the hypothesis that PIBF blockade in recipient rats of CD4+
T cells from PE women treated with 17-OHPC causes a PE phenotype.

Public health relevance
Project Narrative Preeclampsia is associated with increased CD4+ T cells, natural killer (NK) cells, and inflammatory cytokines. Progesterone is crucial for healthy pregnancy, and stimulates progesterone induced blocking factor (PIBF) which is decreased in preterm labor and miscarriage. This proposal focuses on determining if progesterone supplementation, in the form of 17-OHPC, decreases inflammation, hypertension, endothelial dysfunction, and thereby prevents the development of intrauterine growth restriction (IUGR) during preeclampsia.